Characterizing the Relationship Between Alcohol Consumption and Neuron-Derived Exosomal MicroRNA Cargo in an Adolescent-Young Adult Twin Cohort

Project Summary
Alcohol is the most commonly used and misused substance amongst adolescents and young adults. Alcohol
consumption during early life can produce persistent neurobiological consequences given that adolescence/young
adulthood is a critical period characterized by significant and ongoing brain maturation. Investigating the
neuropathophysiology salient to alcohol use (AU) is challenging given that brain tissue from living humans is not readily
accessible for longitudinal measurement. We propose to circumnavigate this challenge by investigating the role of
extracellular vesicle cargo in AU neurobiology of young people. ECVs are membrane-bound sacs that transport
biologically active materials throughout the body.8 They are released by all tissues as a normal part of physiology,
including brain neurons, and deviations in blood plasma ECV characteristics have been associated with psychiatric,
substance use, and cognitive disorders. In particular, comparative ECV cargo analyses are of interest because ECV
cargo reflects tissue of origin and may be used to infer functional roles for ECVs in target cells, pathophysiology, and
treatment responsiveness. MicroRNAs (miRNAs) comprise a majority of blood plasma ECV cargo36, making them the
best initial target for basic science ECV research. MiRNAs are attractive candidates for understanding the genetic
architecture of AU in their own right and have been associated with AU in animal and human studies. Importantly, ECVs
from brain cell lineages can be accessed in peripheral blood plasma, providing an opportunity to index brain biological
processes that may be salient to AU neurobiology. We propose to leverage existing biospecimens to measure ECV-
miRNAs and investigate AU pathophysiology in a sample of adolescents and young adults during a period of high AU.
Specifically, this proposal will leverage data collected from an existing cohort (Parent R01 MH101518; Ntotal=860 twins;
ages 15-22; 57% female) to improve our understanding of ECV-miRNA cargo, particularly those deriving from neurons,
to add to the current understanding of the neurobiology of early life AU. We will select N=313 participants (ages 15-22;
52% female) from the parent R01, which included a broad and rich assessment of alcohol use, concurrent substance
use, psychiatric history and symptoms, and environmental exposures (e.g., parenting, life stressors/adversity).
Participants in the parent R01 also provided blood from which plasma was separated. This R21 proposal will address
critical basic science questions about the nature of circulating miRNAs in young people and their relationship to AU early
in life.

Public health relevance
Project Narrative Early life alcohol use is a prevalent and significant public health problem associated with negative immediate and long-term effects. Perturbations of microRNAs (miRNA) has been linked to a number of disease states in animal models and human studies, including chronic alcohol use. In this application we propose to investigate bulk ECV- miRNAs as well as ECV-miRNAs released from neuronal tissues in an extant, deeply phenotyped subsample (n=313; 15-22 years; 52% female) who participated in a parent R01 study (MH101518) to address critical basic science questions about the nature of ECV miRNAs signatures associated with early life alcohol use.